Data Coordination for the AMP Autoimmune and Related (AR) Knowledge Portal Part B

Project Summary/Abstract
The AMP-RA/SLE program is developing genomic variants, transcriptomics, CyTOF, and histology data on
disease relevant tissue from individuals diagnosed with Rheumatoid Arthritis and Systemic Lupus
Erythematosus. This proposal is designed to extend the work of the AMP-AD Data Coordination Center (AD-
DCC) grant (U24AG061340) to support the coordination and dissemination of activities of the AMP-RA/SLE
program. Specifically, this work aims to expand the access to resources being developed in the AMP-RA/SLE
program by using the systems, processes and technology developed in the AMP-AD program to both increase
within consortia sharing and broader sharing with the research community. Due to similarity in data structure
being between collected in the AMP-RA/SLE program and the structure to the data currently being hosted
through the AMP-AD program, a supplement mechanism was used to provide rapid support of AMP-RA/SLE1
(U24AG061340-03S3). This proposal builds on work done in the initial funding period to support the management
of existing AMP-RA/SLE Phase I and Phase II resources by enabling upload of new Phase II data, expanding
on features of the proposed Autoimmune and Related Knowledge Portal (ARK Portal), and by positioning the
ARK Portal to accommodate requirements from the AMP-AIM program in the future.

Public health relevance
Narrative The Accelerating Medicines Partnership AMP-RA/SLE program is developing rich and varied high-dimensional omic data through characterization of single cell populations collected from both >100 synovial biopsies in rheumatoid arthritis and >200 renal biopsies in lupus nephritis. By creating an open and transparent research ecosystem, this program will combine research from a wide array of experts and research domains across the broad research community.